A biophysical assay targeting Gyrase RNA

PROJECT SUMMARY
The world is rapidly heading towards a pre-1940’s scenario when it comes to fighting infectious disease.
Antimicrobial resistance is a growing problem on a global scale, greatly hampering our abilities to quell
worldwide epidemics such as tuberculosis and malaria, as well as the simple staphylococcus infection .
The proposed project is significant because unless innovative strategies are developed to
produce robust and effective new classes of antibiotics, health care costs will continue to climb
and we will completely lose our ability to combat even the most common infection. Current
antibiotic treatments originated predominantly from natural products produced by fungi and bacteria that
were able to inhibit the growth of other organisms, usually by inhibiting cell wall synthesis or maintenance
or by inhibiting protein synthesis. Since penicillin was first isolated by Fleming in 1929, most of the
subsequent generations of antibiotics remain very similar to the original natural products, wit h functional
groups modified to increase their activity across a broader range of pathogens and decrease their side
effect profiles. Oxazolidones, glycopeptides, -lactams, and quinolones show some promise for the
future, but Gram-negative bacterial infections still remain problematic.
Cases of multidrug-resistant (MDR, resistance to 2-3 classes), extensive drug resistance (XDR, resistance to
most classes except colistin or tigecycline) and even pan drug resistance (PDR, resistance to all classes)
nosocomial bacterial infections have skyrocketed in recent years, and the emergence of pan drug-resistant
isolates are making these infections increasingly difficult to treat. Hospital-acquired infections like these
account for up to 4% of all hospital stays in the United States and are incredibly diverse in causative pathogen,
antibiotic resistance profile, and severity. A significant cause of nosocomial infection is the Enterobacteriaceae
family, which includes Gram-negative bacilli that can be commensal or pathogenic. Enterobacteriaceae have
a widespread clinical and economic impact due to the diversity of infections they cause; this family causes
many infections such as pneumonia, bloodstream infections (BSIs), urinary tract infections (UTIs), and intra-
abdominal infections (IAIs). The World Health Organization (WHO) lists carbapenem-resistant
Enterobacteriaceae (CRE) as having a critical need for novel antibiotics on their Priority Pathogens list.
Because the mortality of these multi drug-resistant infections is between 30 and 50% and there is such difficulty
in finding viable treatments, the need for novel therapeutics for these pathogens must be addressed.
Nucleic acids are promising avenues for drug design, both as therapeutics and as targets. Targeting heavily
conserved RNA sequences and structures, in bacteria (Enterobacteriaceae), and involved in proliferation and
survival of bacteria, is a promising approach. Using our proprietary probes, assays and libraries, we
propose to develop a screening assay for an essential gene in Enterobacteriaceae. Here we propose an
innovative plan for identification of a novel class of ligands that are specific for an mRNA present in
an essential gene in bacteria, and we propose a biophysical screening assay for identifying such
ligands. First, as outlined in Specific Aim 1, we will characterize a model nucleic acid domain that will be
synthesized commercially and identify specific and high-affinity aminosugar binders. We will then synthesize
sequence-specific RNA binding ligands and screen this targeted library of conjugates for sequence-specific
binding and gene inhibition. The mechanism of action will be confirmed using a reporter gene assay (Specific
Aim 2). A successful application of the approach will allow us to identify and validate lead compounds for
inhibition of bacterial growth in Phase II studies.

Public health relevance
PROJECT NARRATIVE Antimicrobial resistance occurs when microorganisms (often infectious bacteria, viruses, and certain parasites) are no longer sensitive to drugs that were previously used to treat them; this is of global concern because it hampers our ability to control infectious disease and increases the costs of health care. In order to combat this world-wide problem, innovative strategies for antibiotic drug design must be implemented. This project addresses this emergent problem by targeting an essential mRNA sequence in gram negative bacteria, by using a novel in-house biophysical screening assay to sequence-specifically block bacterial growth.